Hawaiian, Asian American, and Pacific Islander (HAAPI) Coordinating Center

SUMMARY/ABSTRACT
People of Asian, Hawaiian, or Pacific Islander (AsA-NHPI) ancestry, while representing 7.7% of the US
population, have been largely underrepresented from NIH-funded prospective epidemiologic studies. As a
result, there are large gaps in our knowledge of the burden and causes of cardiovascular, metabolic, and
mental health disorders in these populations. Individuals of these backgrounds have experienced, to varying
degrees, the barriers, stresses, and stereotyping experienced by other minorities while also having challenges
that are unique to them. Understanding the heterogeneity of their lifestyles and societal and environmental
circumstances, as well as their ancestry, is a critical first step in determining their health needs and how to
address them. The heterogeneity in these populations, followed longitudinally and contrasted with other
populations, may add unique insights into the etiology of both physical and mental health conditions. In this
application for the Hawaiian, Asian American, and Pacific Islander Coordinating Center (HAAPI-CC), we
propose to: (1) Bring exceptional scientific, statistical, and cultural expertise to the effort of assessing the
physical and mental health and their determinants in people of Hawaiian, Asian, and Pacific Islander ancestry;
(2) Provide the operational, data science, and biorepository infrastructure and leadership to support the
scientific priorities of the cohort and stimulate and enhance ancillary study opportunities broadly; (3)
Coordinate and support Clinical or Community Field Center (CCFC) activities to enhance recruitment and
retention and broader community engagement; and (4) Enhance career development of early stage
investigators, particularly those from under-represented backgrounds. Through this effort, we can estimate the
prevalence of cardiovascular diseases and risk factors and mental health conditions, study their interplay and
trajectories over time, and examine associations with novel exposures derived from data linkages and
biospecimens. We anticipate leading a number of ancillary studies to obtain additional rich data from novel
sources (wearables, mHealth, genomics, proteomics, metabolomics, microbiome, cardiac and brain imaging).
Through these efforts, we and our CCFC colleagues, will advance the knowledge of the health conditions of
Asian, Hawaiian, and Pacific Islanders and provide the infrastructure for deeper understanding of their
biological, environmental, and sociological underpinnings.
,

Public health relevance
PROJECT NARRATIVE To advance our knowledge of the cardiovascular, metabolic, and psychological health of Asian Americans, Native Hawaiians and Pacific Islanders (AsA-NHPI), we will recruit a population-based cohort of several distinct AsA-NHPI populations from 4-6 Clinical or Community Field Centers and assess a wide range of risk factors and health outcomes using rigorous, culturally appropriate methods. Our diverse team of investigators has deep expertise in cardiovascular and nutritional epidemiology, biostatistics, medicine, immigrant health, behavioral science, geospatial methods, mobile health, laboratory science, and genomics, as well as extensive experience coordinating the activities of large, multi-center prospective cohort studies to contribute to and enhance this effort. This cohort will also serve as a platform for numerous additional ancillary studies that will further address the health concerns of AsA-NHPI individuals.